Identification of new ribosylation-dependent immunoregulatory factors

Abstract The evolution of multiple antibiotic-resistant pathogens for which treatment moieties are limited or absent makes it essential to identify exploitable IMMUNE PATHWAYS to improve the efficacy of vaccines against infectious agents. LT-IIb, a type II heat-labile enterotoxin (HLT), is a potent mucosal and systemic adjuvant that augments antigen (Ag)-specific immune responses and elicits protection against pathogenic challenge in several mouse immunization models. Enhancement of Ag-specific immune responses by LT-IIb, a bacterial ADP-ribsosylating toxin, is regulated, in part, by its capacity to induce expression of IL-6, IL-1β, and several other cytokines by immune cells. Current dogma is that the immunomodulatory properties of LT-IIb are mediated by the toxin’s capacity to ADP-ribosylate the GSα regulatory subunit of the trimeric GSαβγ complex, which constitutively activates adenylate cyclase (AD) in cells, eliciting a dramatic elevation in the intracellular concentration of cAMP, a strong secondary signaling molecule. Preliminary experiments from our lab, however, CONTRADICT that dogmatic model. We show that: (i) forskolin, an agent that strongly activates AD without requiring ADP-ribosylation of GSα, fails to augment Ag-specific immune responses and does not induce IL-6 or IL-1β in immune cells; (ii) pharmacological agents that inhibit AD and the GS trimer have no effect on elaboration of IL-6 by immune cells; and (iii) LT-IIb(E59K/E110K)], an ADP-ribosylase-deficient mutant HLT, neither enhances immune responses to co-administered Ag nor induces production of cytokines in immune cells. Thus, the capacity of LT-IIb to mediate responses in immune cells requires an intact ADP-ribosylase activity, but does not require GSα , AD, or cellular cAMP. Eukaryotic cells express ADP-ribosylases that modify proteins to regulate non-immune pathways. We surmise that LT-IIb is mimicking an endogenous enzyme that modulates responses in immune cells. Our HYPOTHESIS is that the immune responses augmented by LT-IIb are regulated by the toxin’s capacity to ADP-ribosylate one or more proteins operating within an, as yet, undescribed immunoregulatory pathway in B cells, macrophages, and other types of immune cells. To isolate the protein(s) in murine B cells and macrophages that are modified by LT-IIb, we will employ LT-IIb as a MOLECULAR PROBE and a recombinant polypeptide with strong binding for ADP-ribosylated proteins as an affinity agent. Modified proteins obtained from cell lysates using this affinity agent will be identified using a sophisticated, in-house-developed, high-resolution proteomics technology that is NOT BROADLY AVAILABLE and designed to identify proteins in EXCEPTIONALLY LOW CONCENTRATIONS and WITHIN COMPLEX MIXTURES. In a complementary set of experiments, human proteins modified by LT-IIb will be identified using a “total human proteome” microarray. These EXPLORATORY experiments will open new avenues of research into the roles of ADP-ribosylation in immunomodulation. On a practical level, defining this new regulatory mechanism will facilitate development of new and safer adjuvants for vaccine use.

Public health relevance
The current evolution of multiple antibiotic resistant pathogens makes it a critical endeavor to identify new immunological pathways to exploit for increasing the efficacy of current and future vaccines. Herein, we propose experiments to identify a heretofore unknown ADP ribosylation-dependent regulatory mechanism in immune cells using LT-IIb, a potent systemic and mucosal adjuvant, as a molecular probe.